Boron-containing antimalarial drug discovery

PROJECT SUMMARY
New drugs to treat malaria, ideally with unique chemical structures and mechanisms of action, are urgently
needed. Optimal drug candidates for the treatment and prevention of malaria will have potent activity against
cultured parasites and in animal models of malaria, be rapidly active against erythrocytic malaria parasites, be
orally bioavailable, have extended pharmacological exposure, and be safe for administration to humans. This
application builds on prior studies by our group that identified benzoxaboroles as promising antimalarials and a
Phase I SBIR project between Reactive Biosciences and UCSF that identified two new series of boron-
containing compounds with potent antimalarial activity. Phase II of this program will allow us to execute a
thorough lead optimization program designed to deliver a candidate antimalarial compound that is potent,
orally bioavailable, and safe for use. Accordingly, our specific aims will be to: 1) optimize the antimalarial
activity and drug-like properties of lead boron-containing compounds, 2) characterize mechanisms of action
and resistance to drive lead optimization, 3) characterize the pharmacokinetic profiles, in vivo antimalarial
efficacy, and safety of optimized boron-containing antimalarials, and 4) advance an optimized boron-containing
compound to Candidate status.

Public health relevance
PROJECT NARRATIVE New drugs to treat malaria are urgently needed; this project is a Phase II SBIR drug discovery collaboration between Reactive Biosciences and UCSF to discover and develop new antimalarial medicines. This program will include the lead optimization of promising boron-containing antimalarials identified in Phase I, evaluation of drug-like properties of these compounds, mechanism of action studies, profiling of activity in animal models, and safety. Ultimately, these studies will lead to the identification of a candidate compound for development as a new drug to treat and prevent malaria.